Shared Resources Management

PROJECT SUMMARY
Shared Resources are organized and maintained to meet the scientific needs of members of the Stanford Cancer
Institute (SCI). Through SCI-supported Shared Resources, SCI members have access to state-of-the-art
equipment, instrumentation, technical expertise, training, and education—all designed to support highly
innovative cancer research. As a matrix Cancer Center, the SCI is solely responsible for the management of two
Shared Resources and supports nine others that are jointly managed with the School of Medicine (SOM) and
University. CCSG funds are being requested for the support of the following eleven shared resources: Animal
Tumor Models, Biomedical Informatics, Bioscience Screening, Biostatistics, Cancer Imaging, Cell
Sciences Imaging, Flow Cytometry, Genomics, Human Immune Monitoring, Proteomics, and Tissue
Procurement.
In 2020, Dr. Artandi appointed Holden Maecker, PhD, Professor of Microbiology and Immunology, as the
Associate Director for Shared Resources. Maecker is also the Director of the Service Centers and Enabling
Technologies for the SOM, providing integration of SCI member needs into the overall shared resource planning
and evaluation process. SCI administration oversees the management and reporting of the Shared Resources
and receives feedback through annual surveys of users and from the Shared Resources internal advisory
boards. The Senior Leadership Cabinet provides oversight for the overall scientific and strategic development of
Shared Resources. Over the current funding period, the $6M amount of funding for the Shared Resources from
the CCSG was augmented by $2.1M annually in SCI institutional support with a strong return on investment as
documented by usage metrics and publications. The CCSG budget contribution to SCI Shared Resources is only
$1.1M (8%) of the total operational budget ($14.4M, including CCSG and SCI funds) for all Shared Resources
in CY20, with the remainder supported by institutional funds and chargebacks or grant support. The SCI requests
$1.5M in annual support for eleven Shared Resources and two developing Shared Resource in the next funding
period, which will be leveraged by additional $2M in SCI funds.